SAFETY OF IRBESARTAN COMPARED WITH LISINOPRIL IN PATIENTS WITH HEART FAILURE

The purpose of this study is to compare the relative efficacy of irbesartan with lisinopril for improving functional capacity (assessed by exercise treadmill time {ETT} following 12 weeks of treatment.